Quantitative Neuroscience: Tools for Bridging Levels of Analysis

Project Summary
This is a proposal to continue a long-standing postdoctoral training program at Brandeis
University. This program integrates intensive quantitative and experimental training in a
collaborative environment to produce neuroscientists who go on to successful careers applying
these skills to solve the myriad problems posed by disorders of the nervous system. We will take
a diverse and talented set of individuals with Ph.D.s in neuroscience, physics, math, computer
science, engineering, and biological sciences and give them systematic and integrative training
in the use of modern quantitative/analytical approaches bridging levels of analysis to
understand nervous system function. We have designed a modular and collaborative training
structure that allows trainees with disparate backgrounds to acquire the skills, training and
flexibility they need to thrive as modern neuroscientists. Our program comprises a two-year
sequence that systematically builds quantitative literacy, fluency with statistical methods and
quantitative tools, training in rigor, experimental design and ethics, and grant-writing and
communication skills. We intend to recruit 4 Postdoctoral Trainees/year into this 2-year
program for a total of 8 slots, which maintains the previous level of support. We will magnify the
impact of this training program by encouraging all Neuroscience postdocs, not only those
appointed to the training grant, to participate. This will serve the purpose of building a
collaborative postdoc community that collectively possesses and disseminates a broad set of
quantitative skills, and where horizontal and vertical transmission of these skills will be an
important feature of training. The richer this trainee and mentor community is, the more
effective the training will be. To this end, we are committed to enhancing the diversity of our
training program at all levels, and a set of concrete steps to accomplish this are proposed.

Public health relevance
Project Narrative Brain disorders are responsible for significant pain, suffering and economic cost. To facilitate the understanding of brain function and the development of new therapies for brain disorders, this program will produce a generation of quantitatively strong and diverse brain scientists.